Academic Learning Health System Preventions for Promoting Health Equity (aLHS-PRE) Predoctoral Training Program

PROJECT SUMMARY/ABSTRACT
A critical barrier to realizing the promise of prevention in the academic Learning Health System (aLHS) is the
insufficient number of investigators with the skills to cross the research-practice chasm and create health
systems in which new knowledge is integrated into clinical practice, not just for treatment but to prevent disease
and improve population health. We propose to develop clinician prevention scientists – who are grounded in
several rapidly evolving, but infrequently integrated focus areas and competencies, including: 1) health equity
and health disparities research (including measurement of disparities; stakeholder engagement; leadership and
research management; systems science and organizational change; and addressing social determinants of
health and promoting health equity); 2) development and implementation of prevention interventions (including
research questions and standards of scientific evidence; ethics of research and implementation in health systems
and the community; and study design and development of multi-level interventions); and 3) methodological and
statistical approaches (including implementation science methods; health system research methods; biomedical
informatics; biostatistics and data science; and scientific communication). We propose an innovative academic
Learning Health System Preventions for PRomoting Health Equity (aLHS-PRE) T32 program to provide the next
generation of clinician prevention scientists with the methodological and professional skills to conduct rigorous
research in complex multi-level environments across multiple domains, including health systems, and to
disseminate and implement findings from research into practice, utilizing a framework to reduce health disparities
and promote health equity through: (1) building competency in the above focus areas, (2) building skills in team
science and leading interdisciplinary, diverse research teams; and (3) preparing trainees for productive research
careers. The aLHS-PRE will target outstanding predoctoral candidates who are underrepresented in prevention
research who are currently pursuing doctoral-level clinical training in health professions. We will have a cohort
of five trainees who will pursue an established MS degree in LHS science with a curriculum designed around the
competencies above; trainees will conduct a mentored research project guided by diverse mentoring teams
consisting of experienced and committed subject-matter experts, health system leaders, and “step ahead”
faculty, all of whom are well-grounded in the principles of effective mentoring. Mentors will complete the Clinical
and Translational Science Institute (CTSI) Mentor Academy that addresses core mentoring competencies. The
aLHS-PRE will be part of an integrated educational infrastructure at Wake Forest (WF) CTSI that includes a
postdoctoral TL1 program in aLHS; trainees will utilize CTSI resources, attend professional development
seminars, and build networks with other WF T32 trainees. This unique training experience will prepare trainees
for future careers as clinicial prevention scientists leading integration of preventive care in the health system.

Public health relevance
PROJECT NARRATVE The Academic Learning Health System Preventions for PRomoting Health Equity (aLHS-PRE) T32 program will provide the next generation of clinician prevention scientists with the methodological and professional skills to conduct rigorous research in complex multi-level environments across multiple domains, including health systems, and to disseminate and implement findings from research into practice, utilizing a framework to reduce health disparities and promote health equity. The aLHS-PRE will offer a predoctoral training experience that will lead to a Master of Science in Learning Health System Science; trainees will conduct a mentored research project that addresses a pressing health system issue. They will be guided by teams of experienced and committed faculty who are subject-matter experts and well-grounded in the principles of effective mentoring.